Integrative Analysis of the Blood Plasma and Tumor Microbiome: A Novel Approach to Liquid Biopsy Screening for Early Epithelial Ovarian Cancer Detection

ABSTRACT
Women at risk for epithelial ovarian cancer (EOC) are in dire need of new approaches to detect early disease
and novel studies are essential to advance our knowledge of how the EOC tumor microenvironment contributes
to cancer initiation. Innovative approaches in microbial profiling can facilitate breakthroughs in the
discovery of key molecular pathways that contribute to EOC and drive the development of novel liquid biopsy
microbial-based quantitative assays for screening women in clinical practice settings. In preliminary studies, we
have identified patterns and changes in known gut bacteria from plasma and fecal samples that may be related
to ovarian malignancy. The detection of EOC-associated plasma bacteria would be highly favorable for screening
particularly in the deadliest EOC histologic subtype, high-grade serous ovarian carcinoma. The overall objective
of this proposal is to validate plasma bacteria in women with EOC and investigate the source. Our central
hypothesis is bacteria found in the plasma of women with EOC originates from the ovarian tumor site. The
rationale for this proposal is to determine if bacteria in the plasma can provide a means of early disease detection.
To attain the overall objective, we will pursue the following two Specific Aims. Our first aim is to identify and
validate candidate bacterial species as robust biomarkers to differentiate ovarian cancer cases from benign
disease and other solid tumors. Our second aim is to evaluate plasma and intratumor bacteria for concordance
in women with EOC. To achieve Aim 1, we will isolate nucleic acids from the plasma samples of women with
EOC, non-EOC solid tumors, benign gynecologic conditions, and healthy controls and apply 16S rRNA gene
sequencing to assess for differences in bacterial diversity and abundance; verify absolute abundance of the
EOC-associated bacteria with quantitative PCR; and assess the informative bacteria biomarkers for sensitivity
in plasma using samples from asymptomatic women before and after a clinical diagnosis of EOC. To achieve
Aim 2, based on our prior preliminary data and newly discovered pathobionts that have high association with
EOC, we will enrich plasma bacterial extracellular vesicles (BEVs), as a paracrine conduit to intra-tumoral
bacteria and measure their abundance through the copy number of their respective 16S rRNA signature using
droplet digital PCR and correlate with bacterial 16S rRNA gene levels in tumor samples. Subtle pathological
changes are shown to facilitate paracellular transport of BEVs released from bacterial cells, and therefore, BEVs
can be used to correlate EOC grade, stage, and/or histology of the tumor. The application of reproducible BEV
microbial markers unique to early ovarian cancer would be vastly innovative to this field. This study proposal
contributes to a dynamic change in thinking from the traditional notion of “infectious diseases” as the potential
drivers of ovarian carcinogenesis to the mindset that noninfectious migratory gut bacteria could be pivotal to
disease. Thus, this exciting proposal will elucidate bacteria and BEVs (as clinical markers) that are exclusive to
EOC tumors specifically for the early detection of ovarian cancer.